Orchestrating tryptophan metabolites to protect neurodevelopment from prenatal stress

Project Summary: Prenatal stress is pervasive and negatively impacts both the mother and the developing
fetus; exposed offspring bear an increased risk of developing psychiatric disorders including autism spectrum
disorder (ASD), anxiety, and depression. There is a converging line of evidence from our lab, and others, that
prenatal stress alters maternal commensal microbes in a manner that is essential in shaping neurodevelopment.
Indeed, there is a critical window in utero where neurodevelopment is both vulnerable to stress-induced
alterations in the intrauterine environment and able to benefit from intervention. However, how alterations in the
maternal intestinal microbiome are transmitted to the developing brain, contributing to behavioral alterations,
requires elucidation. We have exciting supporting and preliminary data suggesting that Tryptophan (Trp)
metabolism and transport is dysregulated in our model of prenatal stress. This is critical because bacterial
metabolism of tryptophan results in the production of key neuromodulatory metabolites. For example, higher
levels of 3-hydroxykynurinene has been implicated in aberrant brain development and inflammation, and indole
containing compounds, such as indole-3-acetic acid are beneficial. We have further identified that Parasutterella
excrementihominis (Pe), a Trp metabolizer, is significantly reduced in repeated experiments using our mouse
model of prenatal stress. We have exciting preliminary data demonstrating that replenishing Pe can restore key
aspects of neurodevelopment in offspring disrupted by prenatal stress, including social behavior and fetal
inflammation. Therefore, to further our understanding of the transduction of peripheral microbial signaling to the
developing brain, we will pursue our novel finding of dysregulated tryptophan metabolism following prenatal
stress by establishing the extent to which Pe treatment modulates fetal microglia and the behavioral effects of
prenatal stress. Next, we will delineate the interplay between Pe and Trp by determining how Trp availability
affects Pe ability to influence offspring neuroinflammation and social behavior. Finally, we will determine whether
Trp metabolites are sufficient to both cause and prevent the deleterious sequelae of prenatal stress using
intraamniotic injection (IAI). Thus, this R01 will test the highly novel, and integrative overarching hypothesis that
treatment with Pe restores the abundance of Trp metabolites, preventing the neuroinflammatory and behavioral
sequelae of prenatal stress and that the metabolites are sufficient to modulate neurodevelopment. This proposal
will address the following questions: 1) Does replenishing Parasutterella excrementihominis prevent stress-
induced increases in Trp, fetal neuroinflammation, and social behavior? 2) What is the interplay between
Parasutterella excrementihominis anti-inflammatory effects and Trp abundance? 3) Are prenatal stress effects
on neurodevelopment mediated through Trp metabolites?

Public health relevance
Narrative: Stress exposure during pregnancy is common and disrupts neurodevelopment, increasing the risk of psychiatric disorders in the next generation. How stress is transmitted from peripheral changes in maternal microbes to the developing brain in utero is an open question, and maternal microbes are a tantalizing target for intervention. This interdisciplinary study will focus on this critical window to determine the ability of a tryptophan metabolizing microbe to prevent early inflammatory abnormalities in the developing brain which result in long term behavioral changes.